Fluorescence Microscopy

In meeting the goals and objectives of FMIC, the center continues to: -Service and maintain state-of-the-art equipment for unlimited access by intramural scientists. -Provide investigator training in the use and analysis of fluorescence and optical-based techniques. -Develop and optimize experimental protocols in collaboration with intramural scientists. -Maintain and develop state-of-the-art analysis tools and protocols in collaboration with investigators -Monitor and incorporate emerging fluorescence and optical technologies that will support the mission of NIEHS into FMIC. During this fiscal year, FMIC has collaborated and supported 46 Principle Investigators from 8 branches/laboratories within the NIEHS DIR. Some publications from this FY resulting from work in the center is listed in the bibliography below: Bibliography Busada JT, Peterson KN, Khadka S, Xu X, Oakley RH, Cook DN, Cidlowski JA. Glucocorticoids and Androgens Protect From Gastric Metaplasia by Suppressing Group 2 Innate Lymphoid Cell Activation. Gastroenterology. 2021. Epub 2021/05/11. doi: 10.1053/j.gastro.2021.04.075. PubMed PMID: 33971182. Carstens KE, Lustberg DJ, Shaughnessy E, McCann KE, Alexander GM, Dudek SM. Perineuronal net degradation rescues CA2 plasticity in Rett syndrome model mice. J Clin Invest. 2021. Epub 2021/07/07. doi: 10.1172/jci137221. PubMed PMID: 34228646. Carstens KE, Gloss BR, Alexander GM, Dudek SM. Modified adeno-associated virus targets the bacterial enzyme chondroitinase ABC to select mouse neuronal populations in vivo using the Cre-LoxP system. Eur J Neurosci. 2020. Epub 2020/11/22. doi: 10.1111/ejn.15050. PubMed PMID: 33220084; PMCID: PMC8137719. Chi RA, Wang T, Huang CL, Wu SP, Young SL, Lydon JP, DeMayo FJ. WNK1 regulates uterine homeostasis and its ability to support pregnancy. JCI Insight. 2020;5(22). Epub 2020/10/14. doi: 10.1172/jci.insight.141832. PubMed PMID: 33048843; PMCID: PMC7710275. Damborsky JC, Yakel JL. Regulation of hippocamposeptal input within the medial septum/diagonal band of Broca. Neuropharmacology. 2021;191:108589. Epub 2021/05/03. doi: 10.1016/j.neuropharm.2021.108589. PubMed PMID: 33933476; PMCID: PMC8217288. Foo ACY, Thompson PM, Chen SH, Jadi R, Lupo B, DeRose EF, Arora S, Placentra VC, Premkumar L, Perera L, Pedersen LC, Martin N, Mueller GA. The mosquito protein AEG12 displays both cytolytic and antiviral properties via a common lipid transfer mechanism. Proc Natl Acad Sci U S A. 2021;118(11). Epub 2021/03/11. doi: 10.1073/pnas.2019251118. PubMed PMID: 33688047; PMCID: PMC7980415. Kar P, Lin YP, Bhardwaj R, Tucker CJ, Bird GS, Hediger MA, Monico C, Amin N, Parekh AB. The N terminus of Orai1 couples to the AKAP79 signaling complex to drive NFAT1 activation by local Ca(2+) entry. Proc Natl Acad Sci U S A. 2021;118(19). Epub 2021/05/05. doi: 10.1073/pnas.2012908118. PubMed PMID: 33941685; PMCID: PMC8126794. Karcz TP, Whitehead GS, Nakano K, Nakano H, Grimm SA, Williams JG, Deterding LJ, Jacobson KA, Cook DN. UDP-glucose and P2Y14 receptor amplify allergen-induced airway eosinophilia. J Clin Invest. 2021;131(7). Epub 2021/04/02. doi: 10.1172/jci140709. PubMed PMID: 33792561; PMCID: PMC8011887. Nacer SA, Letsinger AC, Otto S, DeFilipp JS, Nikolova VD, Riddick NV, Stevanovic KD, Cushman JD, Yakel JL. Loss of 7 nicotinic acetylcholine receptors in GABAergic neurons causes sex-dependent decreases in radial glia-like cell quantity and impairments in cognitive and social behavior. Brain Struct Funct. 2021;226(2):365-79. Epub 2021/01/06. doi: 10.1007/s00429-020-02179-3. PubMed PMID: 33398432; PMCID: PMC8121181. Nichols CE, House JS, Li H, Ward JM, Wyss A, Williams JG, Deterding LJ, Bradbury JA, Miller L, Zeldin DC, London SJ. Lrp1 Regulation of Pulmonary Function. Follow-Up of Human GWAS in Mice. Am J Respir Cell Mol Biol. 2021;64(3):368-78. Epub 2020/12/09. doi: 10.1165/rcmb.2019-0444OC. PubMed PMID: 33290178; PMCID: PMC7909338. Rai P, Janardhan KS, Meacham J, Madenspacher JH, Lin WC, Karmaus PWF, Martinez J, Li QZ, Yan M, Zeng J, Grinstaff MW, Shirihai OS, Taylor GA, Fessler MB. IRGM1 links mitochondrial quality control to autoimmunity. Nat Immunol. 2021;22(3):312-21. Epub 2021/01/30. doi: 10.1038/s41590-020-00859-0. PubMed PMID: 33510463; PMCID: PMC7906953. Sinha BK, Perera L, Cannon RE. NCX-4040, a Unique Nitric Oxide Donor, Induces Reversal of Drug-Resistance in Both ABCB1- and ABCG2-Expressing Multidrug Human Cancer Cells. Cancers (Basel). 2021;13(7). Epub 2021/05/01. doi: 10.3390/cancers13071680. PubMed PMID: 33918289; PMCID: PMC8038154. Squires KE, Gerber KJ, Tillman MC, Lustberg DJ, Montaez-Miranda C, Zhao M, Ramineni S, Scharer CD, Saha RN, Shu FJ, Schroeder JP, Ortlund EA, Weinshenker D, Dudek SM, Hepler JR. Human genetic variants disrupt RGS14 nuclear shuttling and regulation of LTP in hippocampal neurons. J Biol Chem. 2020;296:100024. Epub 2021/01/08. doi: 10.1074/jbc.RA120.016009. PubMed PMID: 33410399; PMCID: PMC7949046. Yan Y, Liu J, Lawrence A, Dykstra MJ, Fannin R, Gerrish K, Tucker CJ, Scappini E, Dixon D. Prolonged cadmium exposure alters benign uterine fibroid cell behavior, extracellular matrix components, and TGFB signaling. Faseb j. 2021;35(8):e21738. Epub 2021/07/11. doi: 10.1096/fj.202100354R. PubMed PMID: 34245615. Yu L, Liu J, Yan Y, Burwell A, Castro L, Shi M, Dixon D. Metalloestrogenic effects of cadmium downstream of G protein-coupled estrogen receptor and mitogen-activated protein kinase pathways in human uterine fibroid cells. Arch Toxicol. 2021;95(6):1995-2006. Epub 2021/04/06. doi: 10.1007/s00204-021-03033-z. PubMed PMID: 33818655; PMCID: PMC8166678.